South Carolina Cancer Disparities Research Center (SC CaDRe)

Project Summary & Abstract
N/A Description is included in the original proposal

Public health relevance
Project Narrative N/A Project Narrative is included in the original proposal